ADMINISTRATION

Specific Aims 1. Provision of an organizational structure to expedite research and promote communication between Program Project components and investigators. 2. Monitor and regulariy review the quality and progress of research 3. Insure adherence to rigorous statistical considerations in experimental design and data analysis 4. Management of fiscal components of the Program Project including reallocation of funds to optimize overall function. 5. Short-range and long-range planning for the enhancement and integration of Program Project facilities. 6. Provide data sharing and data dissemination facilities for the POl

Public health relevance
Statistical rigor in experimental design and data analysis is an important administrative coordinating goal to ensure that all experimental designs meets the highest statistical rigor. Ensuring that all Cores and Projects are co-ordinated is the main goal of this Core.